Identifying Multi-Level Predictors and Outcomes of Oral Anticancer Medication Adherence Initiation and Persistence among Patients with Hematologic Malignancies

Oral anticancer medications (OAM) are becoming standard of care for growing numbers of patients. Multiple
myeloma (MM), chronic myeloid leukemia (CML), and chronic lymphocytic leukemia (CLL) are hematologic
malignancies for which costly, long-term OAMs are a life-extending therapy. However, OAM nonadherence
(i.e., delaying, not starting, taking more/less than prescribed, or stopping use) is a critical understudied issue
that can dramatically affect cancer outcomes. The reasons for poor adherence, the characteristics of those at
risk for poor adherence, and the effects of poor adherence on health outcomes are poorly understood,
particularly in those with hematologic malignancies. Multi-level factors that affect adherence may be unique
based on adherence phase, including initiation (time from prescription to first dose taken) and persistence
(consistently taking as prescribed). Our preliminary data among patients with MM identified 3 distinct OAM
adherence trajectory groups. While almost 63% of patients maintained near-perfect adherence over 6 months,
over 27% began at 85% and dropped below 70%, and 10% had consistently very low adherence (40%). Self-
reported race and ethnicity (non-Hispanic Black/African American and Hispanic vs. non-Hispanic white)
predicted very low adherence, which was associated with reduced quality of life (QOL). System barriers (i.e.,
care delays, specialty pharmacy barriers, insurance approvals, high costs) and symptom concerns influenced
adherence and negatively affected QOL and employment decisions. Our long-term goal is to develop targeted,
culturally sensitive interventions to improve OAM adherence and health outcomes, particularly among groups
most at risk for disparate cancer outcomes. The overall objective of this theoretically guided study is to
comprehensively characterize OAM adherence initiation and persistence and identify temporal correlates with
1) multi-level factors that increase risk for poor adherence and 2) health outcomes in socioeconomically
diverse patients with MM, CML, and CLL. A prospective (pre-therapy [T0] with repeated monthly measures
[T1-T12] for one-year post-therapy initiation), mixed methods design will be used in 306 socioeconomically
diverse patients prescribed long-term OAM therapy for MM, CML, and CLL. Aim 1 is to characterize the
initiation and persistence phases of OAM adherence. Aim 2 will identify multi-level factors influencing OAM
adherence initiation and persistence. Aim 3 will explore relationships between OAM adherence initiation and
persistence and health outcomes (health care utilization, QOL, molecular response, progression-free survival,
overall survival). Aim 4 will explore factors affecting the patient experience of taking OAMs at initiation and
during persistence, based on semi-structured interviews in a sample subset with differing levels of adherence.
This study will fill critical gaps needed to identify those at risk of nonadherence for targeted support and inform
future clinically relevant interventions to improve OAM adherence, contribute to equitable health outcomes, and
inform adherence research for other cancer types.

Public health relevance
Many patients with blood cancers now take pills to control their cancer, but it can be difficult for patients to start these medications in a timely manner and to consistently take their pills as prescribed. The reasons for these difficulties, the patients who face the most barriers, and the effects that delays and inconsistent pill taking may have on patients’ health are not well known. This study describes how long it takes patients to start their cancer pills and how they take them over time; identifies barriers they may face; and how patients’ health may be affected by their ability to start and continue taking their cancer pills.